ADENOSINE'S ROLE IN REDUCED HEART RATE RESPONSE TO EXERCISE IN ELDERLY

This study is examining the role of adenosine in causing the diminished heart rate response to exercise in the elderly. The study compares a group of young and elderly subjects utilizing theophylline as an adenosine antagonist.